MI-CARES: The Michigan Cancer and Research on the Environment Study

Many communities around the U.S. have been failed by private enterprise and governmental stewardship in
protecting their local environments and thus health. The goal of this proposal is to establish MI-CARES: The
Michigan Cancer and Research on the Environment Study to describe and quantify the impact of known and
novel environmental exposures on cancer risk. With MI-CARES we will examine well-established environmental
carcinogens such as air pollution and heavy metals, but also focus on less characterized exposures including
per- and polyfluoroalkyl substances (PFAS), noise, and chemicals in personal care products for which there are
urgent needs to assess carcinogenicity. As disparities in these exposures are common by geographic region,
socioeconomic status, race/ethnicity, and lifestyle, research is required to understand how these factors impact
the relationships between the environment and cancer risk. Michigan (MI) is an ideal location to carry out
research on environmental exposures and cancer risk. Michiganders have experienced a tragic suite of
environmental exposures ranging from contaminated animal feed with polybrominated biphenyls (PBBs) in the
1970s, to the lead contamination of Flint’s water supply, and the highest known PFAS levels of any state. The
“Tri-Cities” area of metro Detroit, a predominantly Black and Hispanic community, is the most polluted region in
Michigan and high-ranking in the entire U.S. These exposures in MI are profound and the strong history of
community engagement makes MI-CARES feasible. In this project, we hypothesize that environmental
exposures impact inflammation, cellular aging, epigenetic regulation, and immune function to ultimately increase
cancer risk. To investigate this hypothesis, we propose to establish MI-CARES, a racially/ethnically diverse
cohort of 100,000 cancer-free men and women aged 25-44 residing in environmental injustice hotspots in MI:
the Detroit metropolitan area, Flint, Grand Rapids, Kalamazoo, Lansing, and Saginaw. We will recruit equal
numbers of Black, Hispanic, Middle Eastern and North African (MENA), and White participants; all but the latter
are underrepresented in environmental and cancer research. Questionnaire, community-level data, and birth
records will be collected for all participants using a life course approach to capture data during critical windows
of susceptibility. Data collection will include information on individual sociodemographics, residential histories,
health, and lifestyle. Lifetime exposures to environmental pollutants will be ascertained through questionnaire,
residential proximity-based measures or models. In addition, biospecimens (blood spots and saliva) will be
collected on all participants. Within MI-CARES, we will form an enhanced measurement cohort (n=1,000 cancer-
free cohort members) and a nested case-control sample (n=250 cancer cases and 250 matched cancer-free
cohort controls) in whom a comprehensive laboratory-based exposure and intermediate cancer biomarker
assessment will be conducted, including PFAS, metals, untargeted metabolomics, DNA methylation, and
inflammation biomarkers.

Public health relevance
NARRATIVE We are proposing to establish the Michigan Cancer and Research on the Environment Study (MI- CARES) which will include 100,000 participants aged 25-44 from Black, Hispanic, Middle Eastern and North African, and White racial/ethnic groups who reside in six environmental injustice hotspots in the state as there is an urgent need to fully understand the association between environmental exposures and cancer among understudied populations. We will study the impact of environmental exposures that are questionnaire-reported (e.g., personal care product use), proximity/model-based (e.g., air pollution and PFAS), and perinatal from linkage with birth records on inflammation measures (e.g., body mass index) as intermediate cancer markers in the entire cohort. We will also study laboratory-measured exposures (xenobiotics, PFAS, metals) and intermediate cancer biomarkers (cellular aging, immune function, inflammation, and metabolic pathway alteration) in a sub-cohort of cancer-free participants (n=1,000) and using a nested case- control design for those who develop cancer (n=250 cases and 250 controls).